Functional-neuroanatomy of high-level visual cortex: a quantitative multimodal approach

Project Summary/Abstract
Perception of ecologically relevant visual stimuli such as faces and bodies is achieved through
two processing streams extending from early visual cortex (EVC) to lateral occipito-temporal
cortex (LOTC) and ventral temporal cortex (VTC), respectively. However, if and how the
underlying microstructure and white matter connections constrain the functional organization
and support neural computations in these visual streams remains poorly understood.
Leveraging advancements achieved in the prior funding period, we propose a unique
multimodal approach, combining functional magnetic resonance imaging (fMRI), quantitative
MRI (qMRI), diffusion MRI (dMRI), anatomical quantification, and innovative computational
modeling to elucidate how structural factors constrain the functional organization of LOTC and
VTC. The research has three main aims. Aim 1 will test a quantitative model of functional-
anatomical correspondence in high-level visual cortex. Using fMRI, analysis of micro- and
macro-structure, the research will quantify the correspondence between macroanatomical
landmarks, cytoarchitecture, and functional regions in LOTC and VTC. Aim 2 will determine
how white matter connections regulate the functional organization of high-level visual
cortex. Using dMRI and fMRI this aim will test (i) if different white matter connections from EVC
to downstream regions contribute to the segregation of functional regions within and across
visual streams, and (ii) if the eccentricity of the origin of these white matter connections impacts
the visual field coverage of downstream regions. Aim 3 will develop and test a
spatiotemporal population receptive field model of responses in visual cortex. This aim
will provide not only an innovative approach using fMRI and computational modeling to predict
responses to a large range of stimuli that vary in size, position, timing, and duration, but will also
provide a quantitative framework to test the impact of top-down attention on basic visual
computations. Overall, the proposed research will significantly advance understanding of high-
level vision by filling in longstanding gaps in knowledge. The research will (1) provide a
parsimonious model of how the microstructure and connections scaffold the function and
computations of both ventral and lateral streams, (2) break new ground in computational models
of visual cortex, and (3) generate innovative multimodal in vivo methods to quantify
microstructural properties of visual cortex. Together, the research has important implications for
clinical conditions that are associated with malfunction of high-level vision including
developmental prosopagnosia, autism, and dyslexia.

Public health relevance
Project Narrative Our proposed research is in-line with the mission of the NEI to advance knowledge of the neural mechanisms of the visual system. We expect our proposed research to significantly advance the understanding the relation between structure, function and computation. The outcome of our research will improve the well-being of individuals in society as it will provide foundational knowledge that can lead to the identification of neurodiagnostic markers of tissue structure and function that can be measured non- invasively within individuals.